HYPERTHERMIA AND RADIATION

We will examine the hypothesis that exposure to inhibitors of protein synthesis immediately before and during hyperthermia protects cells against the lethal effects of heat by protecting against post-hyperthermia inhibition of protein synthesis. We will then determine if the cycloheximide treatment protects cells against chromosome aberrations induced by heat during the S phase that are responsible for cell killing. Next we will measure the effects of cycloheximide before and during hyperthermia on protection against hyperthermia-induced radiosensitization during the S phase. One aspect of the hypothesis that thermotolerance is due to the synthesis of recovery proteins will be tested. This will be done by examining the effects of a further temperature shock on maximally thermotolerant cells with cycloheximide present before and during the second exposure to hyperthermia.